Role of hyaluronan in YAP signaling on TMJ health and pathology

Abstract
The temporomandibular joint (TMJ) controls jaw movement and function during speech and mastication and
comprises the mandibular condyle, articular disc, and glenoid fossa. These structures exhibit a
fibrocartilaginous organization whereby the apical tissue layer, rich in stem cells and chondroprogenitor cells,
regulates normal growth and remodeling by supplying chondrocytes to underlying cartilage. While these
aspects of TMJ biology are well understood, other functions remain unclear, such as how the
stem/chondroprogenitor cells are maintained, whether changes in these cells underlie TMJ osteoarthritis (OA),
or if other factors instigate pathogenesis, including TMJ lubrication. Hyaluronan/hyaluronic acid (HA)
lubricates the TMJ and is used to alleviate OA symptoms, providing only short-term relief. Studies in other
fields indicate that HA has additional physiological roles, including cell signaling, which may also apply to the
TMJ. Notably, Has1- and Has3-null mice exhibit no significant skeletal abnormalities, suggesting the limited
roles of these isoforms in skeletal development. Our preliminary studies reveal that Has2 is prominently
expressed in condylar chondroprogenitor cells and chondrocytes. Conditional ablation of Has2 leads to
changes resembling TMJ OA, with neither Has1 nor Has3 compensating for its loss. Early phenotypic changes
in Has2-mutant condyles include disrupted chondrogenesis, impaired chondrocyte maturation, increased
expression of the HA-processing enzyme Tmem2, and elevated nuclear translocation of YAP. This is further
supported by siRNA-mediated knockdown of Has2 in primary condylar chondroprogenitor cells, which results
in increased YAP nuclear translocation and decreased proteoglycan synthesis compared to controls. This leads
to our central hypotheses that (i) HA is not only a TMJ lubricant but is also required for the preservation and
functioning of TMJ skeletal stem cells, chondroprogenitors, and their progenies and (ii) pathological HA decreases
and fragmentation would alter the phenotype of those cells via aberrant activation of YAP signaling. In Aim 1, we
will investigate the regulatory mechanisms of HA synthesis and processing in both healthy TMJ and those with
OA using scRNAseq. We will assess the impact of HA depletion on cell function in Has2f/f;AgrCreER TMJs.
To gain insights into tissue stiffness, elasticity, and lubrication, we will measure their mechanical properties at
the nanoscale and surface boundary lubrication. Additionally, we will test whether HA fragments contribute to
YAP signaling, leading to dysregulation of cell function in condylar chondroprogenitor cells isolated from
porcine embryos. Aim 2 will test whether YAP ablation ameliorates TMJ OA. To expand treatment options, we
will evaluate whether YAP inhibitors can prevent or inhibit TMJ OA. This project is based on new data and
novel insights into roles played by HA in TMJ health and disease and will test the efficacy of drug therapy.
Given its novelty, the project is in its early stages but will undoubtedly have significant implications for basic
research and translational medicine for TMJs and other joint-related musculoskeletal diseases.

Public health relevance
Narrative TMJ diseases affect approximately 10% of adults in the United States alone. Loss of hyaluronan/hyaluronic acid (HA) may contribute to the onset and progression of TMJ disorders. This project aims to further elucidate the role of HA on skeletal stem cells, chondroprogenitors and their progenies in TMJ health and pathology, and test specific treatments to prevent TMJ degeneration.